EVALUATION OF MULTI DOSE REGIMEN L-753,037 IN AFRICAN AMERICANS WITH HYPERTENSION

To demonstrate that L-753,037 exerts an antihypertensive effect in a patient population where endothlin blockade is expected to be efficacious.